Investigating the role of PPAR gamma in clear cell renal cell carcinoma

DESCRIPTION (provided by applicant): Clear cell renal cell carcinoma (ccRCC) is the most common and malignant subtype of kidney cancer, which carries a poor prognosis due to resistance to conventional chemotherapy and radiotherapy. Two molecular hallmarks of ccRCC are constitutive transcriptional activity of the hypoxia-inducible factor (HIF) proteins and storag of excess neutral lipid species in cytoplasmic lipid droplets. While recent studies have proposed that metabolic reprogramming of glycolytic and lipid anabolic processes are central to ccRCC tumorigenesis, factors imparting a lipogenic quality to these tumors remain incompletely characterized. The overall goal of this proposal is to elucidate mechanisms of regulation and functional roles of PPARγ in promoting ccRCC progression. Our preliminary data suggest that PPARγ, a master regulator of adipogenesis and lipid metabolism, is overexpressed in ccRCC tumors relative to normal kidney tissue and plays a critical role in maintaining viability of ccRCC cell lines. However, the mechanisms by which PPARγ promotes robust growth in ccRCC remain undefined. In Aim 1, I will test the hypothesis that HIF-1α mediates deregulated lipid metabolism in ccRCC through direct transcriptional activation of PPARγ. I will perform experiments to establish a HIF-1α-PPARγ axis, and characterize downstream changes in lipid metabolism that promote ccRCC progression. Moreover, I propose to identify a comprehensive set of PPARγ target genes in ccRCC through ChIP-seq and microarray experiments. In Aim 2, I will test the hypothesis that the lipid chaperone FABP6, which is associated with copy number amplification, mRNA overexpression, and nuclear localization in ccRCC tumors, enhances the activity of PPARγ. Previous reports suggest that fatty acid binding proteins (FABPs) can potentiate the activity of nuclear receptors including PPARγ, through delivery of activating ligands. Our preliminary experiments have demonstrated a significant block in proliferation in ccRCC cell lines following FABP6 suppression, yet the pathways FABP6 influence in ccRCC are not well understood. Together, these experiments will reveal how PPARγ is regulated and functions to maintain tumorigenesis in ccRCC. A better understanding of the factors which mediate altered lipid metabolism will lead to the development of novel, targeted therapies against this disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Clear cell renal cell carcinoma (ccRCC) is the most common and malignant subtype of kidney cancer, yet is resistant to current standard of care therapies. Through a more detailed understanding of how alterations in lipid metabolism promote ccRCC progression, the experiments outlined in this proposal will identify novel therapeutic targets for this disease.